CHILDHOOD CANCER SURVIVOR STUDY

ABSTRACT
The Childhood Cancer Survivor Study (CCSS) is a multi-institutional, multi-disciplinary collaborative research
resource established to systematically evaluate long-term outcomes among children diagnosed with cancer
who survived five or more years from diagnosis. With the successful recruitment and longitudinal follow-up of
the cohort that includes survivors diagnosed and treated over three decades (1970-1999), the CCSS is the
world’s largest established open resource for survivorship research with 38,036 eligible survivors available for
investigation of late mortality, and 25,665 participants who have contributed health-related and quality of life
outcomes. The resource includes comprehensive annotation of treatment exposures, ongoing longitudinal
follow-up and an established biorepository from which genotype (SNP array) and DNA sequencing of 8,380
survivors are available to investigators for identification of genetic susceptibility for disease- and treatment-
related late effects. The current supplement application will expand the resource to provide methylation
profiling data for more than 2,800 participants.

Public health relevance
NARRATIVE Survival rates for many childhood and adolescent cancers have improved at a remarkable pace over the past five decades. The CCSS cohort has been the source of some of the most significant publications to date addressing the long-term mortality, morbidity and quality of life of survivors of childhood cancer. Understanding the risk for late effects of childhood cancer and its therapy provides the basis for health screening recommendations and interventions that can mitigate long-term health problems in this high-risk population